Alveolus on a chip model of non-tuberculous mycobacteria infection

Project Summary
Nontuberculous mycobacteria (NTM) infections have emerged as a significant public health concern, particularly
in individuals with compromised immune systems and those with underlying pulmonary conditions. The
intricacies of NTM pathogenesis and the limited availability of appropriate in vitro and in vivo models for studying
NTM infections have hindered our understanding of the disease and the development of effective therapeutic
interventions. This project aims to address this critical gap by using a cutting-edge humanized lung-on-a-chip
model to investigate NTM infections in a physiologically relevant environment. Our research leverages the
innovative lung-on-a-chip technology, which mimics the structural and functional complexity of the human lung
alveolus, to provide a platform for studying NTM infection. This model is a fully human system built with primary
cells including human lung alveolar cells, pulmonary vascular cells and immune cells, and incorporates a
dynamic microenvironment that closely replicates the physiological conditions of the lung. By introducing a
variety of NTM strains into this humanized alveolus, we will gain insights into the key steps of NTM pathogenesis,
host-pathogen interactions, and identify potential therapeutic targets. We will pursue the following Specific Aims:
1. We will take advantage of the system we successfully established with Mycobacterium fortuitum to determine
the transcriptional response of airway cells to NTM infection, and the impact of airway immune responses to
NTM survival. 2. We will use the alveolus-on-a-chip system to study innate immune mechanisms controlling NTM
infection in the alveolus, and the role airway NTM infection plays in triggering recruitment of myeloid cells from
the vasculature. The proposed work is expected to identify how model human airways respond to NTM infection
along with discovering common and unique responses to the panel of NTM species tested.

Public health relevance
Project Narrative Nontuberculous mycobacteria (NTM) infections are a growing concern, yet the lack of suitable in vitro and in vivo models has hindered our understanding and development of improved treatments. This project employs a cutting-edge humanized lung-on-a-chip model, closely resembling the human lung, with which we we aim to achieve two specific goals: first, to explore airway cell responses and their impact on NTM survival, and second, to study innate immune mechanisms to NTM in the human airway and the role of cell-derived signals in recruiting myeloid cells during NTM infection. This research will enhance our understanding of NTM pulmonary infections, which have significant public health implications, and may lead to better treatments.